The TENDAI study: Task shifting to treat depression and HIV medication nonadherence in low resource settings

Background. HIV care has been rapidly decentralized in high-prevalence countries like Zimbabwe, in the
drive to expand access to antiretroviral therapy (ART) and to achieve viral suppression in people living with
HIV/AIDS (PLWH).1,2 Optimising adherence to simple affordable regimens is especially critical in settings
where third-line ART is barely available. Depression in Zimbabwe, like elsewhere, is common in PLWH3
and a key barrier to ART adherence.4 There is a dearth of interventions for depression and poor ART
adherence which are feasible for non-specialists to deliver. These facts underscore the public health
significance of focusing on those with depression and a detectable viral load receiving ART regimens.
Preliminary work. We have conducted extensive preliminary work to evaluate the cultural appropriateness
and feasibility of a stepped care, task-shifted intervention for treating depression and non-adherence in
Zimbabwe. Using available lay adherence counselors, this intervention links with the existing Zimbabwean
HIV care pathway. We 1) culturally adapted the Life-Steps adherence intervention through qualitative
studies and tested it in 100 PLWH,5 2) developed a combined depression-adherence intervention called
TENDAI (meaning ‘thankful’ in the Shona language) through integrating the adapted adherence
intervention with Problem-Solving Therapy for depression (a simple culturally-acceptable treatment for
depression used in Zimbabwe)6 and 3) successfully completed an open trial and then a pilot randomized
trial of TENDAI.7 Together, these studies show feasibility, acceptability and potential beneficial effects on
depression, adherence, and HIV viral suppression. Our combined US, UK and Zimbabwean consortium
bring together a history of successful trials in HIV and depression.8-10 Our proposal is strongly endorsed by
the Ministry of Health AIDS and TB Unit. Design: we propose a two-arm effectiveness RCT of the TENDAI
intervention in HIV clinics in rural Zimbabwe in 290 people on ART (first, second or third line treatment) with
a detectable viral load (=> 1000 viral RNA copies) and clinically significant depression. The TENDAI
intervention will be compared to Enhanced Usual Care (EUC). Primary outcomes at 12 months (Aim 1)
include proportion of HIV viral suppression in each condition, adherence to ART (assessed electronically
and by ART detection in Dried Blood Spot), and depression (assessed via a locally validated questionnaire
by an independent evaluator). We will also test (Aim 2) moderators (sex, depression severity) of the
treatment effect, and examine changes in adherence and depression as mediators of the effect on viral
suppression. Through collecting resource utilization and cost data we will examine the cost-effectiveness of
our novel treatment compared to EUC on reduced depression and, potentially, on better HIV outcomes
(Aim 3). If successful, the RCT results will enable us to recommend a strategy for adherence counseling
and depression care locally and in the east and southern African region.

Public health relevance
Zimbabwe has the 5th highest prevalence of HIV globally, with high rates of viral non-suppression and of drop-out from HIV care. Depression is commonly co-morbid with HIV infection in Zimbabwe, as it is internationally, and is consistently associated with worse adherence to antiretroviral therapy (ART). A task- shifted intervention for depression and ART adherence, suitable for delivery by non-specialists, could make a critical difference to the health and survival of people managing the challenges of HIV treatment in Zimbabwe and potentially in other sub-Saharan African countries.